2',3'DIDEOXYINOSINE AND ZIDOVUDINE WITH HIV AND LONG TERM ZDV THERAPY

Randomized, double-blind study to compare the toxicity and efficacy of DDI and ZDV in HIV infected patients with aids, ARC, and low CD4 counts or asymptomatic with low CD4 counts and more than 48 weeks of ZDV experience.